The role of oral microbiota in metastatic brain tumors

PROJECT SUMMARY
Brain metastasis is a major clinical challenge associated with high morbidity and mortality. Growing evidence
suggests a critical role for the immune system in the pathophysiology of brain metastasis. Our group and others
have demonstrated that microbiota, i.e. the assembly of microbes residing within the human body, plays a major
role in shaping immune responses and tumor immunity. However, the impact of different microbial communities
on brain metastasis remains poorly understood, limiting our ability to harness the power of accessible and cost-
effective microbiome modulation strategies to enhance clinical care and improve the outcome of brain metastasis
patients. My postdoctoral studies demonstrated, for the first time, that the brain metastasis tumor
microenvironment harbors intracellular bacterial signals, confirming the existence of a tumor microbiome in brain
metastasis tumors. Importantly, this tumor microbiome was enriched in oral bacteria, suggesting that the oral
microbiota plays a role in the formation of the tumor microbiome in brain metastases. Furthermore, spatial
transcriptomic analysis of patient and murine samples demonstrated that the oral microbiota and the orally
derived tumor microbiome can be associated with transcriptional alterations in the brain, involving both resident
microglial cells at early stages and infiltrated innate immune cells at later stages.
Building on these studies, this proposal pioneers the investigation of the impact of the oral microbiota in
brain metastasis development and progression. In Specific Aim 1 (K99 phase), I will elucidate the mechanisms
underlying the formation of the orally derived tumor microbiome in brain metastases. In Specific Aim 2 (K99/R00
phase), I will use longitudinal clinical studies and spontaneous mouse models of brain metastasis to determine
the local and systemic contribution of the oral microbiota in brain metastasis development and progression.
Insights gained from these studies can inform the development of novel diagnostic, preventive, and therapeutic
strategies for metastatic brain tumors.
The mentored phase of this project will be conducted under the supervision of Drs. Jennifer Wargo, James
Allison, and Michael Davies, at the University of Texas MD Anderson Cancer Center, who are world-renowned
experts in microbiome, cancer immunology, and brain metastasis research. An outstanding advisory team will
also provide guidance on the various aspects of this proposal and training activities. My exceptional mentoring
and advisory teams and the rich intellectual environment at the MD Anderson Cancer Center offer valuable
opportunities for successful completion of the proposed research and career development plan. Completion of
the mentored phase of this award will set the stage for a smooth transition to an independent career where I can
integrate the emerging fields of microbiome and brain metastasis research to tackle outstanding questions in
cancer research.

Public health relevance
PROJECT NARRATIVE Brain metastasis, the spread of tumor cells from the primary tumor to the brain, is the most common type of brain tumor in adults and associated with a significantly poor outcome. Different microbial communities reside within our bodies including the oral cavity and can impact tumor development through changing the behavior of the immune cells. This proposal aims to improve our understanding of the role of oral microbes in the development and progression of brain metastasis, with the ultimate goal of providing novel opportunities to develop diagnostic, preventive, and therapeutic strategies to improve the outcome of this disease.